TRACING FOR FORMER FIREFIGHTERS THROUGH CREDIT BUREAU

The objective of this MAO is to determine the vital status and current address of persons under study by the National Cancer Institute (NCI) through the use of credit bureau records for approximately 4050 subjects. The maximum number of searches, including up to 50 additional or supplemental searches, shall not exceed 4100.